Cell Type-Specific Transcriptional Changes Underlying Memory Impairment in Temporal Lobe Epilepsy

PROJECT SUMMARY/ABSTRACT
Temporal lobe epilepsy (TLE) is the most common form of focal epilepsy and is often refractory to medical
management. In addition to seizures, patients often suffer from cognitive comorbidities, with memory impairment
being the characteristic deficit seen in TLE. Despite the severe impact on patients’ quality of life, the mechanisms
underlying poor memory are not understood and therapies that directly address it are limited. Previous studies
in the lab have identified impaired place cell stability in the pilocarpine mouse model of TLE, which could underlie
the spatial memory dysfunction in these animals. The place cell deficits do not emerge until 6-weeks after the
epileptogenic insult (i.e. pilocarpine-induced status epilepticus, SE), suggesting that there are pathological
processes triggered initially that take weeks to degrade hippocampal coding. This delay presents an opportunity
for therapeutic intervention to prevent the degradation of hippocampal spatial representation, and is an important
timepoint to examine for a comprehensive understanding of the cellular and molecular basis of memory
dysfunction in TLE. The main hypothesis of this proposal is that circuit reorganization precedes the changes in
network properties that cause place cell dysfunction and memory impairment, and that modulating circuit
reorganization can improve place cell functioning and memory. Given the great cell type heterogeneity in the
hippocampus, we performed single nuclei RNA sequencing on hippocampal tissue to determine cell type specific
transcriptomic changes. We identified differentially expressed genes (DEGs) a different time points after
pilocarpine-induced SE and focus follow-up studies on astrocytes given their emerging role in cognitive
processing. To enrich for changes relevant to memory impairment, we compared the astrocytic DEGs at 3-weeks
to a previously characterized Alzheimer’s disease (AD) model. AD, like TLE, is a disorder afflicted by memory
impairment and has prominent hippocampal involvement. Within the overlapping genes, there is a functionally
linked subset with roles in proteolysis: Cathepsins B, D, and L (Ctsb, Ctsd, Ctsl) and cystatin C (Cst3). These
candidate genes have each been implicated in AD pathology in humans, although whether their role is protective
or pathogenic is not fully determined. Additionally, while they were identified through analysis of astrocytic DEGs,
they are broadly expressed across many cell types. In this proposal, we will use a CRISPR-mediated gene
deletion strategy to selectively knockout each of these candidates from astrocytes, microglia, and interneurons.
The effects of the knockouts on performance on a memory task will be determined in Aim 1. In Aim 2, the different
knockouts will be evaluated in terms of their effects on hippocampal electrophysiology (sharp wave ripple
occurrence, theta phase locking) and their effects on place cell function. In Aim 3, histological studies will be
performed to evaluate the effects of the knockouts on a cellular level, looking at mossy fiber sprouting and
synapse quantity. These experiments will elucidate the role of the candidate genes on memory processes and
determine what the relative contributions are from each cell type.

Public health relevance
PROJECT NARRATIVE Cognitive impairment is a major comorbidity of epilepsy and may be more disabling to patients than the seizures themselves. This proposal focuses on identifying the molecular and cellular mechanisms underlying memory impairment in temporal lobe epilepsy, which is the most common form of focal epilepsy and is often refractory to medications. Identifying these mechanisms will enable the development of targeted therapeutics to restore memory processes in patients.